CORE 5: ADMINISTRATIVE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Administrative Core provides centralized administration of the COBRE funds and management of communications between the members of the COBRE. Specifically, this core: 1. Administers the funds of the COBRE grant. 2. Schedules and organizes the meetings between the different members of this COBRE including the Internal Advisory and External Advisory Committee Meetings and keep minutes of these meetings. 3. Coordinates and communicates all the scheduled activities between the PI, the Mentors and the junior investigators including "work in progress"/ journal club meetings, visiting speakers series. 4. Schedules and organizes all scientific and academic meetings for the promising junior investigators (PJI) planned by the PI and the Faculty Development Core. 5. Prepares and generates the Progress Reports for the NIH-NCRR officers.